Neuronal Cilia in Hypertension

Project Summary / Abstract
Hypertension is an important public health challenge in the United States due to its high prevalence and strong
association with stroke, myocardial infarction, congestive heart failure, and end-stage renal diseases. Although
effective therapies for hypertension exist, many adults with hypertension remain resistant to treatment. This
makes hypertension an important medical and public health issue and highlight the need to identify new
mechanisms of hypertension. The cilium is an evolutionary conserved organelle that serve as a sensor of
extracellular cues and the transduction of those cues into cellular signaling ultimately affecting a wide range of
cellular and physiological processes. The goal of this project is to study the role of neuronal primary cilia in
hypertension, autonomic dysfunction and body fluid imbalance. We recently discovered that neuronal primary
cilia regulate blood pressure and that hypertensive animals display abnormally elongated cilia in the supraoptic
nucleus, a key brain nucleus for blood pressure and fluid homeostasis. We also uncovered a novel role for the
renin-angiotensin system in the control of primary cilia. Based on these exciting findings, we propose to test the
novel hypothesis that neuronal primary cilia contribute to hypertension, fluid imbalance and sympathetic nerve
activation through a mechanism that involve Angiotensin II type 1a receptor (AT1aR) signaling. We will evaluate
how conditional ablation of cilia in the supraoptic nucleus affects blood pressure, drinking, urine volume, sodium
concentration, plasma osmolality regional sympathetic nerve traffic and neuronal activity in hypertensive mice.
We will also examine how these parameters are affected by AT1aR deficiency in the supraoptic nucleus. Finally,
we will probe the mechanisms underlying cilia regulation by the AT1aR. The current proposal should
fundamentally advance our understanding of the neuronal mechanisms that mediate regulation of blood
pressure, sympathetic traffic and body fluid balance in health and disease. Insights into these mechanisms may
make it possible to selectively interfere with the hypertension and other cardiovascular risks.

Public health relevance
Project Narrative High blood pressure is a major risk factor that promotes the development of many life-threatening illnesses including heart disease. The focus of this project is to understand the brain defects that causes high blood pressure. Thus, results from the current study have the potential of Identifying new targets that can be exploited for therapeutic treatment of high blood pressure.